BioPortal: An Expansive Knowledgebase of Biomedical Entities and Relations

Project Summary/Abstract
This is a request for a supplement to our parent grant, “BioPortal: An expansive knowledgebase
of biomedical entities and relations.” The supplement would allow us to replace the obsolete
server system that provides storage for the more than 1000 publicly accessible biomedical
ontologies managed by BioPortal. The BioPortal system provides access to nearly all the
world’s publicly available biomedical ontologies and controlled terminologies, and it is used
extensively by many secondary resources that are important to the NIH, including the CEDAR
metadata management system and the REDCap system for electronic data capture. Our parent
grant supports continued maintenance of BioPortal and the development of new features that
are important to the biomedical community. Our ongoing work is threatened because the
hardware that provides storage of BioPortal ontologies has already reached the end of its
anticipated lifespan and is beginning to show signs of failure. We therefore wish to replace the
existing server system with modern equipment with an extended period of performance. This
singular equipment purchase will enhance access to BioPortal, ensure that we are able to
continue to extend the capabilities of the BioPortal resource, and enable us to fulfill the specific
aims of our parent grant without fear of server failures. BioPortal is the world’s most widely
accessed knowledge base of biomedical concepts and relationships. The availability of this new
equipment will support both our enormous user community and the scientific goals of our parent
award.

Public health relevance
Project Narrative Biomedical scientists use descriptions of biomedical concepts (and of the relationships among concepts) known as ontologies to standardize how researchers and clinicians talk about biomedical phenomena. BioPortal is a computer system that integrates more than 1000 biomedical ontologies, making it easy for scientists and clinicians to use the resulting knowledge to describe their data, to access information more reliably, to build other knowledge resources in standardized ways, and to bring biomedical knowledge both to the laboratory and to the point of care. The infrastructure that BioPortal uses to store its ontology content has reached the end of its expected lifespan, thus this supplement will allow us to replace the storage unit to extend the durability of the entire BioPortal resource for many more years.